EFFECT OF PHASE OF MENSTRUAL CYCLE OF GH PULSALTILITY AND ON RESP. TO CAP WSE014

Define the effect of gonadal hormones on growth hormone pulsatility and on the response to combined anterior pituitary hormone function test in normal menstruating women.